Infections, immunity, and inflammation in cancer

Infection, immune disturbances, and inflammation overlap in the ways that they damage tissues and promote development of cancer. Major studies under this project include the HIV/AIDS Cancer Match Study and Transplant Cancer Match Study, which link population-based registries of HIV infected people and transplant recipients to cancer registries in the U.S. Additional studies characterize risk factors for specific cancers in these immunosuppressed populations. Risk of non-Hodgkin lymphoma and lung cancer is elevated in immunosuppressed populations. Some studies under this project address the role of chronic infections, immune disturbance, and inflammation in these and other cancers.